Readthrough of disease-causing nonsense mutations by targeted selenocysteine recoding

TITLE: Readthrough of disease-causing nonsense mutations by targeted selenocysteine recoding
PROJECT SUMMARY
Nonsense (stop) mutations comprise about 10% of disease-causing mutations, and are common in Duchenne
muscular dystrophy, cystic fibrosis, and cancer. These mutations cause early termination of translation and lead
to non-functional proteins. Therapies that enable readthrough of these premature termination codons have been
sought for many years with limited success. Existing approaches are limited by lack of specificity, low efficiency,
or the need to deliver small genes.
The amino acid selenocysteine (Sec), sometimes known as the 21st amino acid, is incorporated into human
proteins via recoding of opal (UGA) stop codons. This recoding mechanism is activated by the presence of a
Sec incorporation sequence element (SECIS) in the 3’ untranslated region (3’UTR). This element was shown to
be sufficient to stimulate selenocysteine incorporation and is active even when located far from the UGA codon.
Here we will develop a novel approach for inducing readthrough of opal nonsense mutations through Sec
recoding. This will be achieved through the use of short hybridizing oligonucleotides that bring the targeted
mRNA in proximity to a SECIS element, inducing readthrough in a gene-specific manner, and restoring a
functional protein. In Aim 1, we will screen oligonucleotides that hybridize to both the target mRNA and an
endogenous SECIS-containing transcript. In Aim 2, we will develop a high-throughput cell sorting-based assay,
allowing the identification of optimal oligonucleotides among the combinatorially large number of possible
designs. We will screen multiple possible designs, including oligonucleotides containing a hybridizing part and a
(possibly abbreviated) SECIS element. We will demonstrate our approach using two disease-associated genes
(DMD and CFTR) and validate the identified oligonucleotides in disease cell models.
The proposed approach has several important advantages over currently available therapeutic approaches to
nonsense mutations. First, the oligonucleotides are specific to the targeted gene, reducing concerns of off-target
effects. Second, the same oligonucleotide can potentially be used for any nonsense mutation in the same gene,
reducing development cost and addressing patients with very rare mutations. Finally, safe and efficient delivery
of short oligonucleotides to several tissues has already been demonstrated. Together, the specificity, broad
usability, and use of proven delivery technologies, make our approach particularly attractive for therapeutic
purposes.
Aligned with NIBIB’s interests, this project will develop a platform technology that is applicable to a broad
spectrum of disorders and diseases. If successful, the project will have a tremendous impact on the quality of
life of people suffering from genetic diseases caused by nonsense mutations and from cancer.

Public health relevance
PROJECT NARRATIVE Nonsense (stop) mutations lead to truncated proteins and cause many genetically inherited diseases, such as Duchenne muscular dystrophy and cystic fibrosis, and are also common in cancer. We propose a novel approach based on repurposing an endogenous cellular machinery that reinterprets (recodes) UGA stop codons as a selenocysteine amino acid, hence reestablishing translation of the full-length protein. This project, if successful, will lead to effective oligonucleotide-based therapies for a broad spectrum of disorders and diseases.